Hybrid Effectiveness-Implementation Trial of Massed PTSD Treatment in a Community Substance Use Program

Project Summary/Abstract
Over 20 studies have shown that prolonged Exposure (PE) is a highly efficacious and effective treatment for
posttraumatic stress disorder (PTSD). While PE has been disseminated across many types of treatment
settings, it is still rarely available to substance using populations. This is unfortunate because co-occurrence of
PTSD and substance use disorder (SUD) is extremely common, research points to the importance of treating
both disorders concurrently with effective treatments, and numerous studies have shown PE to be safe and
effective for PTSD comorbid with SUD. One reason for poor dissemination may be that when PE is available to
SUD patients, treatment dropout is high and effect sizes are smaller for PTSD/SUD studies than for primary
PTSD. Higher PE attendance is associated with greater benefit over other treatment. A possible way to
enhance effectiveness is to offer PE in a massed format (M-PE; i.e., multiple sessions per week instead of
once weekly). For PTSD, M-PE has been shown to be effective and reduce drop out compared to weekly PE.
Although most studies of PTSD/SUD treatment have been in outpatient settings, there is indication that M-PE
initiated in intensive outpatient (IOP) SUD treatment can improve attendance and outcomes. Taken together,
the research suggests that initiating PE in a massed format in IOP SUD treatment is an extremely promising
strategy to improve PTSD/SUD outcomes. A critical next step is a pragmatic Hybrid Type I randomized clinical
trial of M-PE initiated in IOP SUD treatment. We propose to compare M-PE with treatment as usual (TAU) to
SUD treatment as usual only (SUD care including a weekly trauma skills group) at the Gateway Community
Services, Inc., a nationally recognized leader in community SUD treatment. Participants will be 168 male and
female GCS patients with PTSD/SUD. Our central hypotheses are that M-PE will result in greater reductions in
PTSD symptoms and substance use as compared to TAU. Our primary aim is to compare the effectiveness of
M-PE to TAU in IOP SUD treatment in impacting PTSD symptoms and substance use. We hypothesize that M-
PE will show greater improvements in PTSD symptom severity at study treatment completion and 1-, 3-, and 6-
months follow-up and less substance use at study treatment completion, 1-, 3-, and 6-months follow-up. We
will also explore differences in treatment arms on patient-centered outcomes, including days of (non-primary)
substance use, depressive symptoms, functioning, quality of life, suicidal ideation, and participant satisfaction.
We will examine gender as a moderator and changes in trauma related cognitions, cravings, and their temporal
association as mediators of change in PTSD and substance use. Finally, we will conduct a mixed-method
process evaluation to understand patients’, providers’ and stakeholders’ experiences with M-PE, explore
barriers to integrating M-PE into IOP SUD treatment, and identify strategies for widespread implementation.

Public health relevance
Project Narrative Among patients with posttraumatic stress disorders and substance use disorders (PTSD/SUD), reductions in PTSD symptom severity are associated with less subsequent substance use. The goal of this pragmatic Hybrid Type I randomized clinical trial is to compare treatment as usual with prolonged exposure, a gold standard PTSD therapy, delivered in a massed format (i.e., multiple sessions per week where patients complete PE in 2- 4 weeks instead of 3-5 months) to treatment as usual for patients with PTSD/SUD in intensive outpatient treatment at Gateway Community Services, Inc., a nationally recognized SUD treatment program. The successful completion of this project can help change the practices that drive treatment for patients with SUD/PTSD, yielding a high public health impact for a challenging comorbidity.